Novel role of alpha-1 antitrypsin in monocyte-driven disease activity in ANCA-associated vasculitis

PROJECT SUMMARY
Candidate: Lynn Fussner, MD, is an early stage investigator in the Division of Pulmonary, Critical Care, and
Sleep Medicine at The Ohio State University who is dedicated to improving care of patients with antineutrophil
cytoplasmic antibody (ANCA)-associated vasculitis (AAV). Dr. Fussner’s patient-oriented clinical and
translational research in AAV has included study of patient outcomes and single biomarkers for predicting
relapses. With this proposal, Dr. Fussner’s goals are to expand her skillset to include advanced statistical
modeling and bioinformatics coupled with understanding of immunological methods to investigate novel
mechanisms underlying the pathogenesis of AAV, and leverage markers and modifiers of those mechanisms for
personalized management of these rare diseases. Career Development Plan: To achieve these goals, Dr.
Fussner and her primary mentor, Dr. Kymberly Gowdy, MS, PhD, have outlined a comprehensive career
development plan incorporating coursework and experiential learning in immunology, biostatistics,
bioinformatics, and strategies for study design in rare diseases. Central to this plan is strong mentorship from
Dr. Gowdy (expert in translational innate immunity in lung and vascular diseases), Ohio State co-mentors, Dr.
Elliott Crouser (pulmonary/critical care physician-scientist, monocytes as biomarkers) and Dr. Guy Brock
(biostatistics/bioinformatics), and international leaders in vasculitis, Drs. Ulrich Specks (pulmonary physician-
scientist at Mayo Clinic) and Peter Merkel (rheumatology physician-scientist at Penn, Director of the Vasculitis
Clinical Research Consortium (VCRC)). Environment: Ohio State’s research environment couples a large
patient population with well-funded multidisciplinary clinical, translational, and basic research infrastructure. This
includes the Center for Clinical and Translational Science and the Davis Heart and Lung Research Institute.
Research: Dr. Fussner will investigate the role of alpha-1 antitrypsin (A1AT) and monocytes as drivers and
markers of AAV. A1AT is the primary inhibitor of proteinase 3, which is the predominant target of ANCAs in the
western hemisphere. Patients with A1AT deficiency alleles have increased risk of AAV, and our preliminary data
indicate that A1AT genotype impacts the clinical phenotype of AAV. Dr. Fussner’s specific aims are: Aim 1:
Determine whether A1AT levels, alone or in combination with ANCA levels and monocyte inflammatory
markers, predict disease activity and clinical phenotype of AAV. Aim 2: Determine whether ANCA-
induced monocyte signatures predict clinical features of AAV and evaluate the impact of exogenous
A1AT. Dr. Fussner will utilize clinical data and samples from two cohorts: (i) patients with AAV with and without
A1AT deficiency alleles from the VCRC, the world’s largest vasculitis biorepository, and (ii) a clinical trial cohort
of patients with relapsing AAV. Patient total and functional A1AT levels, and ANCA-induced monocyte responses
will be analyzed for prediction of disease activity and specific manifestations of AAV. These studies will enhance
understanding of AAV pathogenesis and identify new biomarkers and safer treatment strategies in AAV.

Public health relevance
PROJECT NARRATIVE Morbidity and mortality in antineutrophil cytoplasmic antibody (ANCA)-associated vasculitis are due both to disease manifestations and complications of immunosuppressive therapy. There is an urgent need for markers of disease activity to inform management strategies that better balance benefits and risks of treatment. We hypothesize that monocytes, key regulators of a multitude of immune responses, play an important role in vasculitis pathogenesis, that alpha-1 antitrypsin, tied genetically to the risk of vasculitis, modulates monocyte- driven inflammation, and that both may be valuable markers and potential targets of treatment in vasculitis.